Search for a gene for a cataract and craniofacial anomalies syndrome

An application for access for genotyping at the NIH/JHU Center for Inherited Disease Research was prepared by Dr. Jabs and Wilson in order to obtain a genotypic screen on members of a family with a rare, presumably autosomal recessive, syndrome with congenital cataracts and craniofacial anomalies. Genotyping access was approved and genotyping is currently underway at the Center for Inherited Disease Research.